Blood Research and EnhAnced Training against HIV in South Africa (BREATH-SA)

The renewal of the University of California San Francisco (UCSF)/Vitalant Research Institute (VRI), University
of Cape Town (UCT) and South Africa National Blood Service (SANBS) Blood Research and EnhAnced
Training against HIV in South Africa (BREATH-SA) program will train hematologists and blood bankers to
perform high-quality HIV research to address relevant research questions in South Africa. South Africa needs
ongoing research on its HIV epidemic’s impact on HIV-related hematologic diseases and the national blood
supply. This proposal builds upon a 22-year history of HIV research collaboration between SANBS and
UCSF/VRI and a 10-year research partnership with UCT under the NHLBI-funded REDS-III International HIV
research network. The first five years of our program have made substantial progress towards our previous
specific aims of building research capacity at SANBS and UCT, offering numerous training activities, graduating
13 Master’s and PhD students and achieving a robust publications record. However, our updated needs
assessment has indicated that better career support, increased mentoring and more outreach to historically
disadvantaged institutions is needed to achieve our overarching goal of creating sustainable centers of
excellence in HIV-related transfusion medicine and hematology research enterprise in South Africa. For this
renewal, we propose these Specific Aims: 1) Train the next generation of clinical researchers in HIV hematology
and transfusion medicine to become independent researchers who will address emerging health challenges in
these areas; 2) Strengthen institutional research capacity in applied HIV research at the SANBS Research and
Development Academy and clinical and translational HIV research at the UCT Haematology Division; and 3)
Develop a South African center of excellence in HIV hematology and transfusion medicine that will reach out to
historically disadvantaged institutions and address inequities in research opportunity. We plan a four-tiered
educational approach for trainees at various levels: in-country short courses on clinical research methodology,
protocol design and manuscript preparation will reach a large number of trainees; for a smaller number lacking
skills in study design, biostatistics and data analysis we propose medium-term course work in Cape Town and
San Francisco; for the most promising, Master’s and PhD degree enrollment at the UCT School of Health
Sciences; and for graduates of the program, a new early-stage investigator tier providing career mentorship and
grantsmanship training. All trainees will be mentored as they accomplish research projects, compete for mini-
grants funded by the program and publish manuscripts. Research resources include the HIV lymphoma registry
and clinical resources at UCT, archived data and specimens from the REDS-III HIV research network and real-
time HIV testing data from blood centers. High impact research topics include: HIV lymphoma biology, clinical
course and treatment; HIV-related anemias and malignancies; HIV prevalence and incidence using novel lab
assays; antiretroviral therapy’s impact on HIV testing; and appropriate transfusion therapy for HIV patients.

Public health relevance
This HIV training grant will build upon existing research at our institutions to improve human capacity in HIV- related hematology and transfusion research in South Africa. It aims to improve the academic research stature of the Clinical Hematology division at University of Cape Town and historically disadvantaged partner institutions and to continue to strengthen the Research and Development Academy at the South African National Blood Services. Research will include studies of HIV-positive participants and blood specimens, studies of HIV cure, studies the use novel technologies to detect HIV and implementation science studies directed at HIV-related lymphoma and anemia and exclusion of HIV-infected persons from blood donation.